Understanding health disparities in Pakistani, Bangladeshi and Asian Indian immigrants: the role of socio-cultural context, acculturation and resilience resources

PROJECT SUMMARY
South Asians, comprised predominantly of Asian Indians, Pakistanis and Bangladeshi immigrants, are the
second fastest growing ethnic group in the United States. Our team has created the first longitudinal study of
South Asians called the Mediators of Atherosclerosis in South Asians Living in America (MASALA), which has
demonstrated significantly poorer cardiovascular health in the aggregated South Asian population compared to
other major U.S. race/ethnic groups. However, MASALA has very limited information about the cardiovascular
health profiles for Pakistanis and Bangladeshis since MASALA included 83% Asian Indian but only 6%
Pakistani and 0.5% Bangladeshi immigrants. Studies from the South Asian subcontinent, the United Kingdom,
and Canada have shown significantly higher burden of cardiovascular disease among Bangladeshis and
Pakistanis compared to Indians. Socio-cultural context, including socioeconomic position, immigration history,
cultural background, and neighborhood factors vary across these three South Asian subgroups and affect how
immigrants experience and adjust to a new context, and how they activate resilience resources to cope with
stressors that impact cardiovascular health disparities. Our goal is to expand the MASALA study cohort to
include more Pakistani and Bangladeshi immigrants leveraging new and existing measures to characterize and
understand cardiovascular health disparities in immigrant populations. We propose to recruit 600 Bangladeshi
and 550 Pakistani adults between the age of 40-84 years from greater New York City and Chicago areas to
add to the ongoing MASALA cohort and compare them to Asian Indians enrolled in MASALA. Our specific
aims are to: 1) Determine whether and the extent to which Pakistani and Bangladeshi immigrants have worse
cardiovascular health (diet, physical activity, tobacco use, diabetes, hypertension, dyslipidemia, obesity)
compared to Indian immigrants already enrolled in MASALA. 2) Identify multilevel risk and protective factors
associated with cardiovascular health within and across South Asian subgroups. Test whether acculturation
strategies and resilience resources mediate or moderate the association between socio-cultural context and
cardiovascular health and explain disparities across the three subgroups. 3) To further interpret our
quantitative results, conduct in-depth interviews to elucidate how immigration, acculturation, discrimination, and
resilience resources influence South Asians’ cardiovascular health. Studying diverse immigrant populations
advances the science of health disparities by understanding how biopsychosocial and ecological
characteristics may associate and interact with country of origin to influence cardiovascular health. Our mixed-
methods approach for studying the complex, multilevel interactions influencing cardiovascular health disparities
in South Asian immigrants offers promise for the development of more effective public health and clinical
prevention strategies to reduce CVD disparities.

Public health relevance
PROJECT NARRATIVE South Asians (individuals from India, Pakistan and Bangladesh) have significantly more cardiovascular disease than other U.S. race/ethnic groups. However, Pakistanis and Bangladeshis may have even higher disease burden compared to Asian Indians. We propose to add Pakistanis and Bangladeshis to our ongoing study of South Asians that includes mostly Asian Indians to understand the complex drivers of cardiovascular health disparities in these three diverse and growing immigrant groups.